Intervention to Enhance PrepPersistence Among African American Men Who Have Sex With Men

PROJECT SUMMARY
This R01 application proposes conducting a fully powered randomized controlled trial (RCT) to test the effect of
a patient navigation intervention for Black/African American (B/AA) men who have sex with men (MSM) on
PrEP initiation, adherence and retention in care. B/AA men who have sex with men (MSM) are
disproportionately impacted by the HIV/AIDS epidemic in the United States. Pre-exposure prophylaxis (PrEP),
a once daily medication, can dramatically reduce HIV acquisition risk. However, social and structural barriers
have contributed to suboptimal PrEP initiation, adherence, and retention in care among B/AA MSM. Our prior
NIH-funded pilot study (R34MH109371; MPI: Nunn, Chan, Mena) developed and evaluated an Intervention to
Retain and Adhere MSM in PrEP (RAMP-IT-UP), a brief strengths-based patient navigation program to
enhance PrEP care outcomes among young B/AA MSM. The intervention was found to be highly acceptable
among B/AA MSM and demonstrated preliminary effectiveness. Compared to control participants,
RAMP-IT-UP participants were statistically more likely to initiate PrEP and adhere to PrEP based on pharmacy
fill data and PrEP blood levels. Additionally, RAMP-IT-UP participants were more likely to be retained in PrEP
care at the 3-month and 6-month clinical visits. Specific Aim #1 of this study will conduct a fully powered
randomized controlled trial (RCT to estimate the effectiveness of RAMP-IT-UP in improving PrEP adherence
and care outcomes among B/AA MSM in real-world community health center settings (CHCs). Specific Aim #2
will estimate the cost-effectiveness of RAMP-IT-UP among B/AA MSM attending CHCs compared to standard
of care. We will also determine the cost-effectiveness of differing levels of intensity of navigation services to
prevent HIV based on data collected in Specific Aim #1. Our goal is to develop a cost-effective intervention that
enhances PrEP care outcomes and reduces HIV incidence for B/AA MSM which will be relevant for CHCs
across the US. The long-term goal of this work is to decrease HIV incidence among B/AA MSM, which aligns
with federal Ending the HIV Epidemic and National HIV/AIDS Strategy goals. This application is led by an
experienced team of investigators with a proven track record conducting HIV, PrEP and disparities research in
real-world clinical settings.

Public health relevance
NARRATIVE This R01 application proposes conducting a fully powered trial to test the effectiveness of a patient navigation intervention for Black/African American (B/AA) men who have sex with men (MSM) on PrEP initiation, adherence and retention in care. This study is informed by an R34 pilot intervention that was associated with improvements in PrEP initiation, adherence and retention in care for this population. The objectives of the proposed study are to conduct a fully powered randomized controlled trial and to estimate the effectiveness and cost-effectiveness of the intervention for improving PrEP care outcomes among B/AA MSM in real-world community health center settings.